Role of Notch-1/PLA2-IIA in oral dysbiosis, inflammation, and periodontal disease

The mechanisms by which mucosal responses to the microbiota in the presence of specific pathogenic bacterial
species (e.g. P. gingivalis-Pg), could abrogate the host-microbe symbiotic relationship leading to dysbiosis and
inflammatory disease remain not fully understood. Our pioneering R21 studies demonstrated that Pg-induced
phospholipase A2 group IIA (PLA2-IIA), in a mechanism that involves activation of Notch-1 receptor (N1R) by
Pg gingipains, modulates the antimicrobial properties of oral epithelial cells (OECs). This is consistent with in
vivo and clinical evidence supporting the potent (ng/mL) antimicrobial effects of PLA2-IIA. Noteworthy, oral
bacterial species exhibited differential antimicrobial susceptibility to PLA2-IIA. Moreover, gingival PLA2-IIA
expression and N1R activation were elevated during initiation and progression of periodontal disease, which was
concurrent with oral dysbiosis in non-human primates. In agreement with these observations, new preliminary
studies using mice models demonstrated increased gingival PLA2-IIA expression and N1R activation early after
Pg infection. Remarkably, the oral microbiome of transgenic mice overexpressing PLA2-IIA (PLA2-IIA-Tg)
exhibited significant differences in the abundance of bacterial species (decreased Firmicutes and increased
Proteobacteria) compared to their wild type co-caged littermates. Oral dysbiosis in PLA2-IIA-Tg mice was
associated with changes in the gingival expression of genes involved in intracellular sensing (NOD2), classical
antimicrobial factors (S100a8/S100a9, hBD1), and M1/M2 macrophage chemokines. N1R is a critical modulator
of mucosal immunity; therefore, the ability of Pg to activate N1R in OECs is an exciting and innovative
observation. Preliminary data suggested that other OEC functions/responses (bacterial sensing, apoptosis, and
autophagy) could involve Pg-induced N1R activation. Based on this evidence, we hypothesize that activation of
Notch-1/PLA2-IIA pathway in gingival epithelial surfaces would be an innovative and plausible mechanism by
which pathogens such as Pg could specifically enhance oral dysbiosis, inflammation and periodontal disease. To
test this hypothesis, we propose three specific aims: (i) To determine the role of PLA2-IIA in Pg-induced
oral dysbiosis, inflammation and periodontal disease, (ii) To determine the role of epithelial
Notch-1 in Pg-induced PLA2-IIA and periodontitis, and (iii) To identify and validate oral
epithelial innate responses modulated by Pg through Notch-1 activation. To address these
knowledge gaps, we will use the Pg-induced periodontitis oral gavage model in mouse strains with or without a
natural PLA2-IIA mutation, PLA2-IIA-Tg mice with their WT littermates, epithelial-specific N1R deficient mice,
as well as OEC cultures to validate the role of this pathway in Pg-induced oral dysbiosis and periodontal disease.
These findings will enable a better understanding of the cellular and molecular mechanisms that are specifically
modulated by pathogens to alter microbial communities at mucosal surfaces as well as contribute to the evidence
for future research designed to determine the role of N1R in oral health and other diseases (e.g., oral cancer).

Public health relevance
This research is relevant to public health because it will identify a potential new molecular mechanism through which pathogens like P. gingivalis could be specifically manipulating epithelial innate responses to alter normal host-bacteria interactions at mucosal surfaces that will evolve to dysbiosis, persistent infection and inflammatory disease. Positive findings of these studies will provide new opportunities for the development of innovative approaches to prevent/treat periodontal disease and its potential adverse effects in systemic health.